CENTER FOR COMPUTATIONAL BIOLOGY: COMPUTATIONAL TOOLS CORE

This Core develops tools to facilitate and extend the research efforts made by investigators in computational biology and biomedical computing. We have classified these tools into three categories: 1. Data Analysis: mathematical and computational methods that solve specific problems faced by biomedical investigators. 2. User Interaction: methods by which investigators can interact with both data and algorithms. 3. Knowledge Management: management of information about investigators, projects, programs, and data. This includes automated methods for data access control, file format translation, data provenance, tracking and program execution requirements.